Diffusion-weighted fMRI for presurgical mapping of primary motor cortex in the presence of neurovascular uncoupling (NVU)

Project Summary/Abstract Current state-of-art for preoperative noninvasive planning of tumor resection is to perform task-based blood oxygen level dependent (BOLD) functional magnetic resonance imaging (fMRI). During scanning, a patient performs a specific task to localize brain functional regions related to the task. BOLD fMRI detects alterations in deoxyhemoglobin concentration influenced by hemodynamic factors that occur in response to neuronal activity. The reliance on BOLD signal to represent activity in the brain comes with limitations. One major limitation is that brain activation mapping using BOLD fMRI relies on the tight coupling between hemodynamic changes and neuronal activity. In the presence of brain tumors or other focal brain lesions, the coupling between neuronal activity and the hemodynamic changes occurring in the adjacent vasculature is often disrupted, which is referred as neurovascular uncoupling (NVU). NVU is a major problem in the interpretation of task-based BOLD fMRI maps in the settings of focal brain lesions, as it may lead to spuriously decreased or even absent activation in electrically active, essential functional cortex. As a result, surgical resection of eloquent cortex may occur with resultant postsurgical morbidity. Another limitation of BOLD fMRI, due to its indirect measure of neuronal activity, is that there is a several second offset in both initiation and cessation of the hemodynamic response with respect to actual timing of neural activity. Such a lag in the temporal profile of the BOLD fMRI response becomes more critical in the case of brain tumors. As a result, the BOLD signal is susceptible to “hemodynamic modulations” which decreases the spatial and temporal accuracy of the BOLD signal. To overcome these limitations of BOLD fMRI, a method which is immune to the hemodynamic changes and is more direct representation of neural activity is needed. A promising alternative approach is the use of activation-associated decreases in brain apparent diffusion constant (ADC) observed using diffusion-weighted MRI (DWI). The use of DWI for functional imaging is referred as “diffusion-weighted fMRI (dfMRI)”. DWI is sensitized to water diffusion of underlying tissues in brain. Prior work has shown that brain ADC decreases in activated cortical areas, occurring several seconds before the hemodynamic response detected by BOLD fMRI. These observations therefore suggest that dfMRI is more directly linked to brain activation than traditional BOLD fMRI, and furthermore may be independent of hemodynamic response factors. However, to date there have been no studies of dfMRI in the evaluation of patients with brain tumors. In the current proposal, we aim to investigate dfMRI in the presence of brain lesion- induced disruption of coupling between neuronal activity and hemodynamic changes. We hypothesize that dfMRI may enhance detectability of primary motor cortex activation in the vicinity of brain lesions.

Public health relevance
Project Narrative Our primary aim is to investigate diffusion-weighted fMRI (dfMRI) in the presence of brain lesion-induced disruption of coupling between neuronal activity and hemodynamic changes. DfMRI, which is more directly linked to brain activation than traditional BOLD fMRI, and independent of hemodynamic response factors, may enhance detectability of primary motor cortex activation in the vicinity of brain lesions. Methodology developed in this study is an important step towards our long-term goal of providing more reliable tools for preoperative mapping, in order to minimize the postoperative deficits due to inadvertent resection of eloquent cortical tissue.